Development of an enhanced biodesign curriculum to promote biomedical innovation

Project Summary
In the past five years, under the support of the NIH R25 grant, we successfully developed a
comprehensive curriculum pathway for our undergraduate team-based biomedical engineering
(BME) capstone design courses. In this renewal proposal, we aim to improve the current
curriculum by developing new courses/programs and bringing new partners to the interdisciplinary
design teams, to enhance BME student skill development in biodesign, expand the team
perspective, and improve communication across disciplines. In the next project period, we aim to
achieve the following three goals: 1) Offer an enhanced biodesign curriculum to BME students,
by adding new healthcare topics, global components, a more diverse pool of healthcare mentors,
and a new course structure (i.e., the Vertically Integrated Projects Program), to the current
practice. 2) Develop a Healthcare Device Innovation (HDI) Microcredential Program. Three
courses will be developed for this microcredential program, covering various biodesign topics.
These new microcredential courses will be open to enrollment for not only BME undergraduate
students, but also all healthcare students and practicing healthcare providers within Stony Brook
University and Stony Brook University Hospital. BME undergraduate students will be able to take
these classes as technical electives. These courses will give BME students opportunities to work
directly with a variety of healthcare providers with expertise in general medicine, nursing, dental
medicine, clinical laboratory services, emergency medical services, radiology, occupational
therapy, physical therapy, and social welfare, etc. 3) Establish a new Biotechnology and
Entrepreneurship Internship Program, in collaboration with Center for Biotechnology, the
Intellectual Property Partners Office, and local biotech companies. This new internship program
will provide BME undergraduate students with experiential learning opportunities to observe (and
comprehend) the operational and business side of the biodesign process.
We will recruit, retain and train a diverse group of students/participants in the proposed
educational programs. Quantitative and qualitative analyses will be conducted to assess and
evaluate the programs’ learning and teaching outcomes. The enhanced biodesign curriculum,
microcredential and internship programs will help BME students to learn how to work effectively
with various healthcare providers and other stakeholders during the biodesign process. All these
programs will help BME students to gain practical skills that are needed for the future
bioengineering workforce development.

Public health relevance
Narrative / relevance to public health This project seeks to improve the training of next-generation biomedical engineers and entrepreneurs who will be developing technologies specifically to address unmet clinical needs. By immersing students in a clinical environment, providing them with mentorship from clinicians and industry veterans, and offering them with a pathway for commercializing their designs, we will be improving public health both in the near and long term.